Diversity supplement: Lymphatic regulation of lymph node function in lupus

Summary: Systemic lupus erythematosus (SLE) patients are photosensitive, where ultraviolet radiation
exposure can induce skin inflammation and also trigger systemic disease flares characterized by increased
autoimmunity and organ damage. The link between photosensitive skin and systemic autoimmunity is not well
understood. The long-term goal of the parent R01 is to determine the mechanisms that connect photosensitivity
with systemic disease flares. Skin communicates with the immune system via lymphatic vessels which carry
antigens and mediators to regulate draining lymph node immune function. Within the lymph node, lymph fluid is
channeled into a conduit system ensheathed by fibroblastic reticular cells (FRCs). The FRCs are thus potentially
regulated by lymphatic flow alterations, and in turn can regulate B and T cells responses. How lymphatic flow
alterations may regulate FRC functions is unknown. While lymph may directly regulate FRCs, dendritic cells
(DCs) are in contact with both lymph and FRCs and we have previously shown roles for DCs in regulating FRC
expansion via lymphotoxin beta (LTb) that regulates podoplanin (PDPN)-mediated FRC numbers. The extent to
which DCs mediate a lymphatic modulation of FRCs is unknown. We recently showed that lymphatic flow is
reduced in human SLE and murine lupus models and that improving lymphatic flow reduces lymph node B cell
responses. The parent R01 investigates the hypothesis that lymphatic flow regulates FRC CCL2 expression to
regulate lymph node immune responses and asks about the roles of type I interferon, reactive oxygen species,
and the RNA binding protein IMP2 in lymphatic-regulated FRC function. Our goal with this Supplement is to
extend the investigation proposed in the parent R01. We show in preliminary data that improving lymphatic flow
also results in increased FRC numbers. This was associated with increased FRC proliferation and PDPN
expression, and reduced T cell responses. This expansion was dependent on DCs. The FRC expansion, PDPN
upregulation, and DC dependence recalled the DC- LTbR-FRC axis that we have previously established,
suggesting that improved lymphatic flow-induced FRC expansion could be related to a DC- LTbR-FRC
axis.Thus, we will test the hypothesis that improving lymphatic flow induces expansion of FRC via DCs and their
signals, and the expanded FRCs reduce lymphocyte responses and autoimmunity. Our aims are to 1) delineate
the FRC subsets that expand upon MLD and understand their functional phenotype in vitro, 2) understand the
extent to which migratory vs resident DCs along with LT R are key mediators of MLD-induced FRC expansion,
and 3) understand the effect of MLD and FRC manipulation over the long term on lupus disease phenotype.
This proposal will help us understand how lymphatic function contributes to lupus-like disease and delineate
mechanisms by which lymphatic flow regulates FRCs and by which FRCs regulate T cells. This will lead to a
better understanding of the relationship between photosensitivity and autoimmunity.

Public health relevance
Narrative Patients with systemic lupus erythematosus and other autoimmune diseases can develop systemic disease flares upon even ambient sunlight, but the mechanisms are poorly understood. Here, we will examine the how the flow of information from skin to immune tissues via lymphatic vessels modulates immune function.